WALK AWAY FROM THE HABIT: OVERCOMING NICOTINE DEPENDENCE THROUGH EXERCISE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This study intends to examine the immediate and long-term effects of initiating a novel type of exercise program among sedentary smokers, with the ultimate goal of replacing smoking with brief bouts of exercise.